Bridging the Gap: Enhancing Cancer Care for Underserved Populations with the Veris Health Cancer Care Platform

ABSTRACT
The proposed study aims to optimize and validate the Veris Cancer Care Platform for the needs of medically
underserved cancer patients receiving outpatient chemotherapy. The Veris Health platform is a remote patient
monitoring and communication system designed to bridge the gap between clinical visits and provide oncology
care teams with objective data during high-risk periods.
This study will specifically focus on optimizing the Veris Health platform for patients with language barriers,
limited access to technology, and socioeconomic disparities. By incorporating user-centered design and working
closely with community health centers, the research team will ensure that the platform is culturally and
linguistically appropriate, easy to use, and accessible for all patients.
The study will use a mixed-methods approach to validate the effectiveness of the optimized platform, including
quantitative data analysis and qualitative interviews with patients and healthcare providers. The goal is to
demonstrate the potential for the Veris Health platform to improve outcomes for vulnerable populations by
reducing hospitalizations, emergency department visits, and the economic burden of cancer care.
This study has the potential to lead to a marketable product that can be used by cancer patients across the
United States, regardless of their socioeconomic status, primary language, or access to technology. The Veris
Cancer Care Platform has already been successfully piloted in partnership with New Jersey Cancer Care and is
poised to make a significant impact in the field of remote patient monitoring for cancer care.

Public health relevance
Revised Public Health Relevance/Narrative The Veris Cancer Care Platform is designed to enhance outpatient oncology care by providing continuous physiologic and symptom monitoring, medication adherence tracking, and structured patient-reported outcomes collection. The platform enables real-time communication between patients and care teams and offers timely clinical insights that can inform interventions and reduce acute care utilization. This study will evaluate the feasibility and explore clinical impact of the Veris platform in patients receiving systemic cancer therapy. Special attention will be given to optimizing the platform’s usability in real-world settings, where patients may have varying levels of comfort with digital tools or individual financial or other factors that may impact care. By integrating remote monitoring into routine cancer care, the platform aims to improve clinical decision-making and reduce unplanned hospitalizations and emergency department visits. The study’s findings will inform broader implementation of remote monitoring solutions in oncology, with the goal of improving patient outcomes and care efficiency across a wide range of practice settings and patient populations. The proposed project to optimize and validate the Veris Health Cancer Care Platform is highly relevant to public health. This technology has the potential to improve clinical outcomes, reduce healthcare costs, and enhance care delivery for patients undergoing systemic cancer treatment. By equipping patients with at-home monitoring devices and enabling remote communication with their care team, the platform addresses key gaps in outpatient oncology care, supporting early identification and management of treatment-related toxicities and reducing the incidence of preventable hospitalizations.